A Novel Drug Target for Aggressive Prostate Cancer

Prostate cancer (PC) that recurs following standard of care androgen-deprivation therapy is termed
castration-resistant prostate cancer (CRPC) and is currently incurable. CRPC is marked by reactivation of
androgen receptor (AR) signaling, eventual metastasis and, in some cases, further evolution to AR null/AR
indifferent neuroendocrine PC (NEPC). BUB1B (BUBR1) is a master regulator of a seven gene network that is
upregulated in and drives CRPC. BUB1B is overexpressed in PC compared to benign prostate tissue and is
further elevated in metastatic CRPC (mCRPC) and NEPC. BUB1B is an essential component of the spindle
assembly checkpoint (SAC) and aberrant BUB1B expression has been associated with development of several
cancers; however, its role in PC remains understudied and there are no drug-like inhibitors available.
Depletion of BUB1B halts AR+ and AR- CRPC cell proliferation. Furthermore, ectopic BUB1B expression in
the less aggressive predecessor of CRPC, androgen dependent (AD) PC, is sufficient to confer castration
resistance. Expression of constitutively active AR variants (AR-Vs) is one mechanism underlying progression
to CRPC and clinical resistance to 2nd generation AR antagonists such as enzalutamide. In CRPC cells,
BUB1B knockdown decreased AR and constitutively active AR-V protein stability leading to decreased ligand-
independent AR transcriptional activity, which is a driver of most CRPC and metastatic CRPC. Thus, BUB1B is
a promising therapeutic target for CRPC including, but not restricted to, currently intractable constitutively
active AR-V expressing tumors.
This proposal will test the hypotheses that: (1) BUB1B kinase activity is essential for progression to lethal
CRPC by increasing AR / AR-V levels, which can drive CRPC; (2) in AR null/AR indifferent NEPC, BUB1B
promotes growth through yet to be defined AR-independent mechanisms; and (3) BUB1B represents a
promising but untapped therapeutic vulnerability that can be exploited for treating deadly CRPC and NEPC.
Aim 1 will evaluate the mechanisms underlying BUB1B kinase growth-promoting effects in CRPC and NEPC
and will determine the requirement for BUB1B kinase activity in stabilizing AR/AR-V7 as well as explore
mechanisms of BUB1B promotion of CRPC and NEPC. BUB1B protein will be evaluated in TMAs containing
bone and visceral metastasis, which will be useful for future patient stratification. Aim 2 will establish BUB1B as
a tractable druggable target by evaluating and prioritizing recently identified small molecule inhibitors that
target the BUB1B kinase domain at the ATP binding site. A NanoBRET assay will be developed for BUB1B
drug optimization and advancement. Aim 3 will develop, characterize, and evaluate drug-like potent and
selective small molecule BUB1B kinase inhibitors. Preliminary data support the proposed use of a highly
scalable and innovative computational screening pipeline that integrates AI-based kinase activity predictions,
protein homology modeling, and physics-based molecular simulations to identify and prioritize BUB1B
inhibitors. Structure-activity relationships (SAR) and optimization of at least one identified BUB1B inhibitor
series using biochemical and kinome-wide activity profiling assays will be conducted. The therapeutic efficacy
of BUB1B inhibitors will be evaluated in cell lines and patient-derived xenograft explant cultures representing
the heterogeneity of the human disease.
The multidisciplinary team with deep expertise in PC biology and experimental therapeutics, structure-
based computational screening and medicinal chemistry will focus on the mitotic kinase BUB1B, which
represents a promising therapeutic vulnerability in lethal PC. This proposal will elucidate mechanisms of
BUB1B action in lethal CRPC and NEPC and develop drug-like potent selective small molecule BUB1B
inhibitors through sophisticated deep neural network multi-task (DNNMT) predictors coupled with biochemical
assays and test the most promising compounds in robust CRPC and NEPC patient-derived models.

Public health relevance
Prostate cancer (PC) is the number one cancer diagnosed in US Veterans. Almost half a million US Veterans currently undergo treatment for PC at the Veterans Health Administration. Advanced PC is treated by androgen deprivation therapy and most patients' initial response is favorable. Unfortunately, the cancer usually recurs as aggressive, incurable “castration-resistant prostate cancer” (CRPC) that often metastasizes and dramatically degrades quality of life. To combat or prevent CRPC, new therapies must be found. We identified a gene termed BUB1B (known to increase cell division) that is present at high levels in CRPC and in metastatic CRPC. Reducing BUB1B protein in genetic experiments halts the growth of CRPC cells. For clinical purposes, however, no BUB1B drugs exist. We will determine how BUB1B promotes CRPC growth, pinpoint BUB1B activity that is vulnerable to drugs, and deploy a computational and experimental approach to identify BUB1B drugs. We will validate drug effectiveness in pre-clinical CRPC models and set the stage for clinical trials.